Beckman Coulter Cytoflex Nano for Sub-Micron Flow Cytometry

PROJECT SUMMARY/ABSTRACT
The University of California at Davis (UCD) is a diverse educational institution recognized for excellence in
medical, veterinary, agricultural and engineering education and research. The UCD Medical Center houses the
UCD Comprehensive Cancer Center (UCDCCC), a patient treatment and research center that supports and
coordinates the collaborative research efforts of over 100 cancer researchers. The UCD Flow Cytometry Shared
Resource Laboratory (FCSR) provides cell sorting and analytic cytometry support campus-wide and is used
heavily by UCDCCC members. In recent years, several UCDCCC investigators have begun to study the role of
small, nanometer sized extracellular vesicles, such as exosomes, in cancer diagnosis, metastasis and treatment.
Extracellular vesicles (EVs) are a variety of nanoscale membrane vesicles released by cells that are widely
present in body fluids. The study of EVs is hampered by their small size (≤100nm), as well as their variable
surface protein expression and internal composition. Flow cytometry is a preferred method to rapidly
characterize, enumerate and purify EVs based on size and brightness. However, many clinically-relevant EVs
are between 30-80nm and fall below the limit of detection of most standard flow cytometers. EV research also
requires rigorous isolation and labeling techniques, and detecting EVs apart from instrument and reagent noise
is challenging, especially for novice EV investigators. Certain cytometers, such as the FCSR’s 8-year-old
Beckman Coulter “Cytoflex S”, have sufficiently sensitive optical detectors and other features that allow it to
detect EVs  80nm. For the past four years, this Cytoflex S has supported the EV cytometry needs of UCDCCC
investigators. However, the Cyoflex S was not specifically designed to support consistent, reliable EV
measurements and suffers from periodic optical drift and other issues that are difficult to address. This situation
has led to unacceptable unreliability of the Cytoflex S platform for EV work. Further, at its best, the Cytoflex S
cannot detect EVs smaller than 80nm. Meanwhile, as the role of flow cytometry has gained more importance in
the EV field, new cytometers, like the Cytoflex Nano, have been developed specifically to support EV research.
The proposed Cytoflex Nano, described in this application, is engineered exclusively for EV research, is capable
of detecting particles as small as 40nm, has rigorous cleaning and QC procedures that simplify cytometer setup
and qualification for EV studies and will receive improved maintenance support from the supplier. The success
of NIH-supported EV research at UC Davis depends on the availability of a sensitive, reliable, small particle
cytometer that will simplify the user experience and enable biomedical breakthroughs. The Cytoflex Nano will be
housed in, managed and maintained by the Flow Cytometry Shared Resource facility so that UCD investigators
have access to sensitive, reliable nano-particle detection and EV flow cytometry expertise for years to come.

Public health relevance
Project Narrative The purpose of this application is to request funding for a new 4-laser Cytoflex Nano flow cytometer for the UC Davis Flow Cytometry Core Facility to advance nanoscale extracellular vesicle research. The cytometer will be capable of analyzing very small, sub-cellular components from human and animal tissues, allowing them to be further studied in the laboratory to improve human health. The Flow Cytometry Core is heavily utilized, serving NIH-funded basic and translational biomedical researchers at the UC Davis School of Medicine, School of Veterinary Medicine, the Comprehensive Cancer Center, and the Colleges of Engineering and Biological Sciences.